Clinical Center for NICHD/Neonatal Research Network

ABSTRACT
Children born extremely preterm (EP) (<27 weeks gestational age (GA)) are atincreased risk of having a
languagedisorder or late language emergence 1-5. The proposed study seeks to identify the neural circuit
mechanisms and socio-demographic factors that contribute to variable language outcome in extremely
preterm (EP) children at 3 years corrected age (CA). This supplemental funding application is submitted as
one of a pair of applications from the University of Pennsylvania/Children's Hospital of Philadelphia
(Penn/CHOP) and Cincinnati Children's Hospital Medical Center (CCHMC). The PIs at Penn/CHOP and
CCHMC, Drs. DeMauro and Merhar, are PIs of the NICHD Neonatal Research Network (NRN) Clinical Centers
at their respective institutions, which serve as the parent studies for the current proposal. The NRN follows all
infants born EP and other high-risk infants from birth to 22-26 months CA, collecting developmental outcomes
and therapies received, and perinatal, medical, and socio-demographic data. For the proposed project, they
engaged highly motivated and qualified junior faculty with expertise in neural imaging and language
development from both sites (Dr. Chen from CHOP; Dr. Barnes-Davis from CCHMC). The proposed study
employs a suite of magnetoencephalography (MEG) neural measures and language assessments to evaluate
if task-based neural measures are differentially associated with variable receptive and expressive language
outcome in EP children at 3 years CA in comparison to term-born controls (TC) children. Using tasks
developed by Dr. Chen and Dr. Barnes-Davis, neural measures of interest are: (1) auditory encoding
processes = M50 latency 6-15, (2) functional connectivity during receptive (story listening) and expressive (verb
generation) language processes = weighted phase lag index (wPLI) 16, 17, and (3) resting-state (RS) peak alpha
frequency (PAF), a brain rhythm associated with connectivity between neural networks 18-20. Leveraging both
the existing CHOP NRN cohort with neonatal and completed developmental data at age 2 years and a CHOP
longitudinal TC cohort who have completed longitudinal neuroimaging and developmental data from birth to
age 2, MEG and language measures will be obtained in 60 EP and 60 TC children at 3-3.5 years CA. The
same MEG task data and language outcome measures will be obtained in the EP and TC cohorts at CCHMC,
for a total enrollment of 100 EP and 100 TC participants across two sites, enhancing the power and
generalizability of the proposed study. Sharing of methods and data across the two centers permits rapid and
efficient data collection of a socioeconomically diverse EP sample. It is anticipated that the elucidation of
neural risk factors will provide increased specificity to the nature of variable language outcome in young
children born EP. Study findings are also expected to lead to timely and more tailored clinical interventions that
shape the maturation of language neural networks and specifically meet the goal of the TALK NOSI, “to
engage in activities that will help to elucidate the unique trajectories and needs of late talking children.”

Public health relevance
PROJECT NARRATIVE The proposed study seeks to identify neural mechanisms associated with variable receptive and expressive language ability in children born extremely preterm (EP) at 3 years corrected age (CA). Combining a large socioeconomically diverse EP cohort (N=100) across Penn/CHOP and CCHMC, magnetoencephalography (MEG) neural measures and language outcome measures of EP children will be compared to term-born control children in order to identify altered language neural networks underlying late language emergence. A second study goal is to evaluate the degree to which retrospective clinical, socio-demographic, and developmental data measured at 2 years CA predict language outcome at 3 years CA, and to determine if MEG neural measures improve the model fits for language outcome.